National Science Network on Drug Abuse Annual Conference

This proposal is for renewal of an Annual Conference grant (R13 DA026647), to support five
three‐day, stand-alone conferences. The organizing entity is dedicated to improving population
health by increasing the amount, quality, and dissemination of interdisciplinary translational
research and fostering the development, advancement, and promotion of future scientists and
leaders. The conference assembles members of the global research community focused on
different aspects of substance use disorder including epidemiology, toxicology, environmental
health, intervention science, psychology, sociology, health policy, and neurobiology as it pertains
to all populations. The conference is unique in that it serves as a forum for transdisciplinary
scientific discourse spanning from basic neuroscience to implementation science and policy. The
conference serves as a venue for mentoring, networking, and professional development of
emerging scientists in their respective disciplines. Because many of the sociocultural factors and
comorbid conditions relevant to affected communities are shared across populations, our goal is
to include participants from multidisciplinary fields. The proposed yearly conferences will continue
to serve as a unique venue for transdisciplinary and interprofessional scientific discussions on
strategies towards minimizing the impact of substance use disorders on risk of comorbidities
contributing to health imbalances in affected communities. In addition, the conferences will
continue to foster recruitment, retention, development, and advancement of emerging scientists
to promote future leaders in substance use disorder research and related areas. The conference
is an opportunity for all trainees to come together and participate in a multidisciplinary scientific
meeting, establish peer support groups, and develop professional relationships that provide
venues for innovative developments in the field.

Public health relevance
Persons from all ethnic groups are impacted by substance abuse in the United States. There is an urgent need to develop and mentor emerging biomedical scientists that can address the growing epidemic of chronic comorbidities afflicting those impacted by substance use and related comorbidities. The annual conference is the premier venue for transdisciplinary, interdisciplinary, and interprofessional scientific discussions on strategies to minimize the impact of substance abuse on people from all ethnicities.